Administrative Core

Administration Core
SUMMARY/ABSTRACT
The Administration Core of this NHLBI Program Project Grant will provide general administration and
accounting for all projects and cores. Dr. Horton will direct the core with the assistance of Drs. Goldstein and
Brown. It will facilitate the coordination of activities between research projects and cores and schedule weekly
PPG meetings. The administrative core will carry out all accounting functions, provide assistance with travel
arrangements and reimbursements, order and monitor all supply deliveries, notify project and core leaders of
due dates for the animal research applications, radiation safety applications, biosafety applications, equipment
service contracts, and training courses. It will also organize the internal and external advisory board meetings
and ensure that their recommendations are carried out. The Administration Core will serve the three
component projects and Cores 1 and 2 equally.